PrEP My Way: A Novel PrEP Delivery System to Meet the Needs of Young African Women

PROJECT SUMMARY - Significance: Young women (16-24 years old) in sub-Saharan Africa are a
vulnerable population in terms of HIV acquisition with ~7,000 new infections occurring per week. Oral daily
pre-exposure prophylaxis (PrEP) is a highly effective means of HIV prevention when taken regularly. Early
experience with the global rollout of PrEP in this population indicates enthusiasm for PrEP, but also barriers to
adherence and program retention. Proposed intervention: PrEP My Way is a novel PrEP delivery system
consisting of clinic-based PrEP initiation, followed by peer-delivered kits for HIV self-testing, PrEP refills,
vaginal swabs for gonorrhea and chlamydia self-sampling, pregnancy tests, and contraception refills, if
desired. Based on Social Cognitive Theory, our overall hypothesis is that PrEP My Way will overcome critical
stigma and structural barriers that currently limit PrEP use and thus empower young women to promote their
sexual health. Innovation: This study is the first, to our knowledge, to develop a peer-delivered kit for PrEP
use, sexually transmitted infection (STI) testing, and contraception. The intervention leverages smart use of
readily available technology (e.g., SMS, WhatsApp, Vimeo) to support use of the kit and peer-based
empowerment. Approach: We will first develop, tailor, and refine PrEP My Way for use with young women in
Kisumu, Kenya (Aim 1). We will use a client-centered, iterative approach, involving ~15 individual interviews
and two focus group discussions (with ~5 women each) to optimally design the PrEP My Way kit (with
instructional materials) and peer delivery system (including communication and kit delivery plans). We will
then test the intervention for feasibility, acceptability, and preliminary impact on PrEP adherence and program
retention (Aim 2). We will randomize 100 Kenyan women to PrEP My Way versus standard of care (i.e., clinic-
based delivery of PrEP and sexual health services) and follow them for 6 months. Feasibility will be assessed
by receipt of the kit at 1, 3, and 6 months and ability to use its components per protocol. Acceptability will be
determined through a mixed-methods interview at 6 months. Preliminary impact will be evaluated by dried
blood spot tenofovir levels (adherence) and kit use/clinic attendance at 6 months (retention) as primary
outcomes. Potential influencing and mediating socio-behavioral factors will be explored with questionnaires at
baseline and 6 months. Investigators/environment: Our team has extensive relevant experience to ensure
the success of this proposal, including PrEP adherence and behavioral science (PI: Dr. Haberer at
Massachusetts General Hospital), sexual health service delivery (Dr. Bukusi at the Kenyan Medical Research
Institute, Dr. Baeten at the University of Washington), and remote delivery and monitoring for PrEP and STIs
(Dr. Siegler at Emory), as well as product design (ARK in Nairobi). Future directions: PrEP My Way is
designed with limited infrastructure needs, thus creating potential for real world implementation at scale that
can be tested in a future R01 grant.

Public health relevance
PROJECT NARRATIVE Young woman in sub-Saharan Africa are a prior population for the global rollout of oral HIV pre-exposure prophylaxis (PrEP) as ~7,000 new infections occur each week in this population; early studies indicate high interest in PrEP, but also barriers to adherence and program retention. PrEP My Way is a novel PrEP delivery system consisting of clinic-based PrEP initiation, followed by peer-delivered kits for HIV self-testing, PrEP refills, swabs for sexually transmitted infection self-sampling, pregnancy tests, and contraception refills, if desired. This delivery system is designed to meet the needs of young women on their terms and has limited infrastructure needs, thus creating potential for real world implementation at scale.